Protocol Review and Monitoring System

PROJECT SUMMARY/ABSTRACT
The Protocol Review and Monitoring System (PRMS) of the Tisch Cancer Institute (TCI) oversees all cancer
related clinical research conducted at the Mount Sinai Health System (MSHS). The primary goal of the PRMS
is to assure robust internal oversight of the scientific aspects of cancer-related research by providing a rigorous
initial scientific review and performing ongoing monitoring for scientific progress and accrual of active cancer
protocols. Protocol review is performed in a two-stage review process: Disease- or Modality-Focus Groups,
and the Protocol Review and Monitoring Committee (PRMC). This 2-stage review process increases efficiency
by (i) supporting staff effort in developing protocols and PRMC application materials of greater scientific merit,
(ii) reducing the time from concept approval to protocol activation, and (iii) improving the quality while reducing
the volume of protocols reviewed by the PRMC. The PRMC has the authority to approve protocols that meet
the scientific merit and priorities of the TCI and to terminate protocols that do not demonstrate scientific
progress.